BD FACSymphony A5 Cell Analyzer

Project Summary
Flow cytometry has been the gold-standard in biotechnology for interrogating cellular phenotypes for the past 60
years, and is limited only by the number of cellular parameters that can be simultaneously detected in samples.
The capacity for multi-parametric flow cytometry using spectral-based systems has developed rapidly with the
advancements in lasers and optics capable of more effectively exploiting the visible and invisible light spectrums.
The requested BD FACSymphony A3 Cell Analyzer, with optional FSC PMT, is a state-of-the art five-laser (UV-
355nm, Violet-405nm, Blue-488nm, Yellow-561nm, Red-637nm) system capable of simultaneously acquiring
data on as many as thirty cellular parameters and resolving particles as small as 200nm. Added advantage of
this system is that it leverages the ease-of-use of classic BD instruments, which all Users listed in this proposal
are experienced with, to create an advanced system with a simple user interface. Currently, the only system
available at the University of South Carolina School of Medicine for performing routine cell analysis is a 12-year-
old BD FACSAria II Cell Sorter. This proposal includes 8 Major Users with 16 NIH- and 2 VA-funded research
grants. Our Users perform cutting-edge fundamental and translational research on a variety of human diseases
including inflammatory bowel disease, lupus, atherosclerosis, Gulf War Illness, cardiomyopathy, cancer, and
defects in hematopoiesis. The research programs of our Major Users will be benefitted by acquisition of this
instrument for the following reasons: (1) increased ability to acquire more data per sample by inclusion of more
lasers, (2) enhanced data quality by reducing spectral overlap through the integration of more lasers, (3)
enhanced sensitivity to detect rare cell populations through integration of stronger lasers, (4) the ability to develop
novel assays through inclusion of a yellow-561nm laser, (5) increased ability to discriminate cell populations by
integration of stronger lasers and the ability to use stronger emitting UV and violet dyes, (6) the ability to develop
novel assays for the enumeration of small particles (e.g. bacteria, exosomes, endosomes, mitochondria) by
inclusion of special FSC PMT, (7) flexibility in customization of mirror/filter configurations for User-specific
applications, and (8) the ability to use classic UV dyes (DAPI and Hoescht stains) in flow-based assays through
inclusion of UV laser. Acquisition of this instrument advances the broad and long-term priorities of UofSC to
become a leader in biomedical research in the state of South Carolina. First, it provides UofSC investigators an
advanced platform for studying cellular responses. Second, it enhances the competitiveness of UofSC
investigators for grant dollars by enhancing the complexity of questions that can be addressed experimentally,
by providing a system capable of revealing unanticipated biological phenomenon that will allow investigators to
take their research into new areas, and by enhancing the quality of data that can be used in grant applications.
Finally, availability of an advanced system for multi-parametric flow cytometry will enhance the training of the
next generation of biomedical researchers at the UofSC.

Public health relevance
Project Narrative Studying cellular complexity and cell-cell interactions requires a multi-parametric approach, and advancements in spectral flow cytometry has dramatically increased the number of cellular parameters that can be simultaneously detected in samples. This proposal seeks to justify procurement of a BD FACSymphony A3 Cell Analyzer for the University of South Carolina School of Medicine to enhance the research of several federally- funded investigators. Fundamental and translational research on a variety of human diseases (inflammatory bowel disease, lupus, atherosclerosis, Gulf War Illness, cardiomyopathy, cancer, defects in hematopoiesis) will be significantly enhanced by the acquisition of this instrument.